FEASIBILITY STUDY OF CATHETER ABLATION FOR PAROXYSMAL ATRIAL FIBRILLATION

Surgical creation of linear atrial lesions can prevent recurrence of atrial fibrillation (AF) in selected patients. We hypothesize that radiofrequency (RF) ablation using an innovative RF ablation system and a transcatheter approach will also be efficacious. Patients with paroxysmal AF and normal left atrial size will undergo attempted catheter ablation, then will be monitored for 6 months. This pilot study will primarily address the questions of procedure safety and feasibility, and lead to a randomized trial. Study ongoing.